CORE--TISSUE CULTURE

The Tissue Culture Core will provide two common and essential services to all projects in the program. The specific aims are: 1.To purchase, store, perform quality control and distribute to the investigators reagents including tissue culture media, serum, antibodies and cytokines. 2. To store, maintain and provide to the investigators various cultured cell lines on a regular basis.